ROLE OF CHOLESTEROL ON CYCLOSPORIN A INDUCED IMMUNOSUPPRESSION TOXICITY

Hypothesis to be tested is that, with "therapeutic" whole blood Cyclosporin A levels, low total serum cholesterol levels predispose the allograft recipient to high free CsA levels.